Administration Core

Summary Administrative Core.
The objective of the proposed Center for Pre-Clinical Cancer Research (Cancer COBRE) at
Louisiana State University (LSU) is to elucidate molecular and cellular mechanisms of human
cancer using specialized disease models that are predictive of disease in humans. The
Administrative Core (AC) will oversee overall administrative management of the Cancer
COBRE to ensure successful implementation and to provide the Promising Junior Investigators
(PJIs) with essential support to achieve their research and career goals. The Cancer COBRE is
headquartered at the LSU School of Veterinary Medicine (LSU SVM) but also will oversee
projects and facilities located in the main LSU campus within walking distance to LSU SVM.
SVM trains both future veterinarians and biomedical scientists and offers M.S. and Ph.D.
degrees in Biomedical and Veterinary Medical Sciences, thus the COBRE will greatly enhance
the research training of future scientists. The overall objectives of the AC is to provide cohesive
management and coordination of COBRE activities, to promote a strong mentoring environment,
and to provide a centralized infrastructure and management that will provide specialized pre-
clinical evaluation and technology to support PJI achievement and research independence.
The following specific aims will be pursued: Aim 1. To promote the academic success and
research independence of PJIs through a dynamic and comprehensive mentoring program.
Aim 2. To provide fiscal oversight and administrative support for the COBRE projects and
scientific cores. Aim 3. To promote a research environment that will advance
scientific discovery and foster collaborative research opportunities between the Cancer
COBRE and the scientific community at LSU and in Louisiana.